Not all members of the pregnancy-specific glycoprotein family are created equal

PROJECT SUMMARY
The importance of factors secreted by the placenta as mediators of the immunological adjustments needed to
accommodate the genetically different mother and fetus in species with hemochorial placentation (rodents, non-
human primates and humans) is well recognized. Conflicting interests for resources between mother and
offspring are hypothesized to drive an evolutionary arms race during mammalian pregnancy. This can result in
gene duplication events giving raise to protein families, such as the pregnancy-specific glycoprotein (PSG)
family, which are not uncommon in the placenta. Monocyte (M0) and macrophage (Mϕ) dysregulation are
implicated in pregnancy pathologies such as preeclampsia (PE) and preterm birth and these cells of the innate
immune system are primarily responsible for the release of TNF, a potent pro-inflammatory cytokine. While the
TNF response contributes to trophoblast invasion in the early decidua and to parturition, increased levels of
TNF are also associated with adverse pregnancy outcomes. Therefore, the temporal and spatial regulation of
inflammation represents a complex and essential process required for pregnancy success. Human PSGs, a
family of ten proteins secreted by placental trophoblasts to the maternal circulation throughout pregnancy, are
composed of 3 or 4 Ig-like domains. While PSGs have expanded from a single gene by duplication, it remains
unknown whether after expansion, these genes have acquired different functions. Moreover, due to sequence
similarities, specific antibodies that differentiate each member of the human PSG family are not available, but
studies at the mRNA level have indicated that they are expressed at different levels and times during gestation.
PSG1 has anti-inflammatory activities in vitro and in vivo and the concentration of PSG1 was found to be lower
than normal in African American women diagnosed with PE. In contrast, PSG9 was reported to be upregulated
in PE. Recently, we also observed that treatment of M0 and Mϕ with PSG9 but not with PSG1, PSG4 and PSG7
resulted in increased TNFsecretion. Based on these observations, we propose an innovative hypothesis that
PSG9 has a unique function among human PSGs via binding to a specific cellular receptor in M0 and Mϕ
resulting in the production of pro-inflammatory cytokines by these cells. We propose to test our hypothesis with
the following Specific Aims: (1) Determine whether PSG9 is unique among all the human PSGs in its ability to
induce pro-inflammatory cytokines in monocyte/macrophages and define the domain in PSG9 involved in this
activity. (2) Identify the cellular receptor of PSG9 in monocytes/macrophages associated with its ability to induce
TNF in these cells. Validation of the pro-inflammatory activity of PSG9 and identification of its receptor and its
potential targeting will enable the development of diagnostic tools and novel therapeutic interventions to address
the etiology of some pathological pregnancies. The long-term benefit to surviving offspring and the mother could
have enormous economic and social consequences.

Public health relevance
PROJECT NARRATIVE A better understanding of the physiological mechanisms that underlie immune regulation during pregnancy is likely to provide insights into the etiology of pregnancy complications and will also allow for a better understanding of the mechanisms responsible for the establishment of immunological tolerance. We propose to study the interaction of Pregnancy-specific glycoprotein 9 with monocytes/macrophages and characterize its cellular receptor in these cells.